The Pacific Cancer Research Consortium (PCRC), an NCORP Community Site

PROJECT SUMMARY/ABSTRACT
In 2013, the Pacific Cancer Research Consortium (PCRC) was created to bring clinical trials and
cancer care delivery research to community cancer treatment centers in the Western United States as
an NCI Community Oncology Research Program (NCORP) Community Site. Under a multiple PI/PD
structure, the 3 primary component sites—Swedish Cancer Institute in Seattle, Providence Portland
Medical Center in Portland, and St. Luke’s Cancer Institute in Boise—have facilitated the conduct of
NCORP-sponsored trials at more than 40 affiliate sites in Alaska, Washington, Oregon, Idaho,
Montana, and California. Over the past 12 years, the PCRC built on its collective experience in clinical
research, its shared organizational structure, and its community demographics to deliver accessible
research trials, enhance community engagement in research, and provide quality cancer care. As an
established NCORP Community Site, the PCRC will continue to “bring cancer clinical research studies
to individuals in their own communities” by (1) conducting clinically important treatment trials that
include robust accrual strategies and fair access for everyone, (2) participating in cancer control and
prevention studies, cancer care delivery research, and screening, and imaging trials proposed by the
NCORP Research Bases, (3) optimizing and streamlining procedures to ensure timely and accurate
data submission and specimen collection, (4) enhancing visibility, recruitment, participation, education,
and broad population engagement including patient advocates in NCORP activities, and (5) mentoring
the next generation of community-based cancer clinical trialists.

Public health relevance
PROJECT NARRATIVE (RELEVANCE) The NCORP Community Site outlined in this application comes from our experience building a multicenter infrastructure in the Western United States that excels in patient accrual and fosters new and close collaboration between investigators. We believe that our structure will accelerate the translation of knowledge gained from trials in cancer treatment, cancer control and prevention, cancer care delivery research, screening, and imaging into clinical practice and thereby enhance the science, the treatments, and the delivery of care to patients with cancer in community settings.